CORE--BIOREAGENT AND CELL CULTURE FACILITY

The Bioreagent and Cell Culture Core Facility supports cancer related research that requires in vitro experiments, provides reagents for cell culture and prepares bioreagents that are produced by cells grown in the facility. Recently, the Cell Culture Core facility was reorganized to introduce new services of producing bioreagents that were identified as high priority by the investigators during last year's survey. The Core Facility now grows suspension cultures of hybridoma cells in large quantities and produces purified monoclonal antibodies. A recently acquired News Brunswick Bioreactor made the growing of cells in large quantities possible at substantial savings. The facility is in the process of developing and evaluating lipofectin preparations for cell transfection at highly reduced costs. Additional available services are the preparation of specialized serum products, LB matrix coated culture dishes, and Ampicillin /R plates. Studies will be conducted to evaluated the feasibility of producing recombinant proteins, cytokines and growth factors. The Core Facility continues to provide established services of cell culture media preparations in large batches and their distribution at five convenient locations, testing for mycoplasma contaminations, drug testing using cytotoxity and cell proliferation assays, bulk purchase of tissue culture additives, growing attached cells in large quantities using roller bottles, and provides assistance in all techniques related to cell cultures. The Facility is one of the most widely used shared resources, utilized by 62 faculty members, and provides substantial savings of 45% to 90%.